Pilot Study to Evaluate a Behavioral Activation Prenatal and Postpartum Intervention for Depressed Pregnant Smokers

PROJECT SUMMARY
Smoking and depression frequently co-occur in pregnant women. Independently, both smoking and
depression are associated with numerous adverse birth outcomes and negative impacts on infant and child
health. Although the co-occurrence of depression in pregnant smokers has been noted in the literature, it has
not been addressed in prenatal or postpartum smoking cessation intervention studies. Behavioral activation
therapy (BA) has been found to be an effective treatment for depression in pregnant women. In the current
study, we will adapt an existing BA protocol as a depression-focused intervention for depressed pregnant
smokers. In the general population of smokers, there is accumulating evidence that extended courses of
treatment with multiple counseling sessions result in significantly higher abstinence rates at long-term follow-up
compared to standard treatment courses. The recent development of mobile/internet based software provides
opportunities to deliver intensive, psychotherapeutic interventions via videoconferencing, which potentially
increases the feasibility of providing such interventions to pregnant smokers across the prenatal and
postpartum periods. Smartphone apps and supportive text messaging have been shown to be an effective
adjunct for improving outcomes and increasing participant engagement in in-person psychotherapy treatments.
However, the feasibility of providing psychotherapeutic videoconferencing plus supportive app messaging via
smartphone has not yet been evaluated, nor is the feasibility of extending behavioral smoking cessation and
depression treatments from the prenatal to postpartum periods known. In the current study, we will pilot test
and evaluate the feasibility and acceptability of providing smartphone, videoconferencing-based BA treatment
plus behavioral smoking cessation counseling, and a BA app (BA) to depressed pregnant smokers during the
prenatal and postpartum periods; and will conduct a preliminary evaluation of BA’s effect on abstinence and
depression at 6 months postpartum.

Public health relevance
PROJECT NARRATIVE Maternal smoking and depression during the prenatal and postnatal period are independently associated with negative effects on birth outcomes and child health. Brief interventions to help women quit during pregnancy and prevent relapse in postpartum have not been effective. The goal of this study is to evaluate the feasibility and acceptability of providing extended intensive, depression-focused smoking cessation treatment via real time videoconferencing on smartphones, to depressed, pregnant smokers during the prenatal and postpartum periods; and to evaluate its effect on smoking abstinence and depression at 6 months postpartum.